Structural mechanism of diabetic amyloid formation

Structural mechanism of diabetic amyloid formation
Abstract
11.6% of the U.S. population is afflicted by type 2 diabetes. It starts as insulin resistance, but ultimately
the pancreatic -cells that make insulin fail, resulting in overt diabetes. -cell failure correlates with aggregation
of a hormone called the human islet amyloid polypeptide (hIAPP or amylin) into amyloid plaques in the islets of
the -cells. Surprisingly, the amyloid fibers themselves are not cytotoxic. Many researchers believe that the toxic
species are oligomers of hIAPP that interfere with receptor mediated processes, cause inflammation, or
permeabilize the membrane. The oligomer hypothesis is strengthened by recently reported antibodies that bind
specifically to oligomers and stall type 2 diabetes in animal models. As a result, there is much interest in
elucidating the structures of oligomers and understanding the mechanism by which they form. However,
characterizing kinetically evolving proteins is challenging and so little structural information exists about these
transient oligomers. We invented a technology, rapid-scan 2D IR spectroscopy, that enables us to monitor the
structure of hIAPP as it aggregates. We discovered an oligomeric intermediate with a parallel -sheet in the
FGAIL region and an -helix at the N-terminus. We observed this “FGAIL oligomer” in 4 different mammalian
species known to contract type 2 diabetes, strengthening our hypothesis that this intermediate is a key player in
the disease. Most importantly, we realized that we could trap the oligomer with a few benignly placed mutations.
Our trapped oligomers are nearly as toxic as wild-type hIAPP, but persist in vitro for days rather than hours.
Because they are stable for so long, we could perform 2D/3D NMR and generate the first structural model of an
hIAPP oligomer. Simultaneously, we created a transgenic mouse model that expresses our oligomer, thereby
linking our in vitro oligomer to pathophysiology. In this proposal, we capitalize on our new strategy for studying
the structures and mechanisms of hIAPP oligomers. Aim 1 refines our structural model, Aim 2 extends our
approach to a hereditary missense mutation that causes early onset-diabetes, and Aim 3 tests our in vitro
hypotheses with matching transgenic mouse models. We seek to understand hIAPP aggregation from a
fundamental perspective and link our in vitro structural mechanisms to in vivo physiology. We believe that our
approach is unique to the structural biology community, providing much desired structural and mechanistic
information about hIAPP aggregation and its relationship to type 2 diabetes.

Public health relevance
Project Narrative Amyloid deposits in the pancreas are a distinctive characteristic of type 2 diabetes. Research suggests that it is not the deposits themselves that cause -cell failure and loss of insulin production, but transient species that are cytotoxic. Knowledge about these transient species will help inform new therapies to combat the disease.